COMMON INSTRUMENTATION AREA AND TECHNICAL SUPPORT UNIT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Common Instrumentation Area and Services Unit (CIAS) has the objective of providing the investigators at UCC with the major equipment and services that are needed for developing and executing high quality research projects. There are over 25 very active investigators (many with projects funded by RCMI, SNRP, MBRS, DOD, INBRE and CNS) who rely heavily on this core facility. The CIAS houses instrumentation such as high speed and ultra-centrifuges, a gel documentation system, a scintillation counter, a gamma counter, water distillers and ice machines that are not available elsewhere at the University and therefore, the CIAS fosters equipment sharing and centralizes maintenance of equipment. In addition, the CIAS provides a common cell culture room for new and established investigators who do not have the facilities in their own laboratories and as a backup facility for investigators with cell culture hoods and incubators. Under the umbrella of the CIAS, there is a machine shop and an electronics workshop. These workshops are maintained by two technicians who are dedicated to fulfilling the needs of the scientific community at UCC. In this proposal, we request funding to continue to conserve and upgrade the existing facilities and resources initially funded by RCMI including the common instrumentation, the electronics shop and the machine shop. The following specific aims form the basis of our plan to maintain, fortify and expand our infrastructure for scientific research. Aim #1: to provide UCC faculty with the necessary equipment to be productive researchers. Aim #2: to update the existing instrumentation. Aim #3: to develop an equipment calibration service Aim #4: to continue the electronics workshop and precision machine/carpentry shop components. Aim #5: to continue the Facilities Monitoring System (FMS).